Microbiota depletion ameliorates sickle cell induced vaso-occlusive crisis and organ damage

Project Summary:

As the most common inherited blood disorder in the United State, there are 70,000-­100,000 Americans with
sickle cell anemia. Sickle cell disease (SCD) is caused by a mutation in the β-­globin gene, which leads to
significant deformation red blood cell (RBC) membrane and promotes RBC adhesion to other cells to induce
vaso-­occlusive crises (VOC). Chronic sickle cell anemia is accompanied with progressive systemic multi-­
systemic organ dysfunction and cost over $475 million annually in hospital admission. Our laboratory has
reported that sickle cell-­induced hypoxic, oxidant, and inflammatory stress is perpetuated by aged neutrophils
which positively correlates with VOC in humanized SCD mice. Our recent work has demonstrated that deletion
of the microbiota in SCD mice by antibiotics restricted aged neutrophil expansion which consequently decreased
VOC severity, and reduced organ damage as well as the iron overload. In addition, hydroxyurea, the only FDA-­
approved drug for SCD that promotes the anti-­sickling fetal hemoglobin expression, also possesses anti-­
inflammatory, antiradical, and metal-­chelating activities both in mammalian cells as well as in bacteria.
In this application, we propose a 3-­year experimental plan that will advance our understanding in the function of
microbiota in SCD disease progression and will test whether manipulation of the microbiota will provide a
potential novel SCD treatment. In Specific Aim 1, we will identify disease-­modifying microbiota species that may
contribute to neutrophil aging and SCD organ damage. 16S sequencing data has revealed microbiota differences
between antibiotic treatment and untreated SCD mice, and the function of selected microbiota will be verified in
germ-­free SCD mice. In Specific Aim 2, we will examine if hydroxyurea reduces VOC and organ damage through
microbiota manipulations in SCD mice in which fecal samples from hydroxyurea-­treated and control SCD mice
will be transplant to germ-­free SCD to evaluate whether hydroxyurea-­induced changes in the microbiota
contribute to its therapeutic activity. In Specific Aim 3, we will study if iron restriction (by DFO or low-­iron diet) or
probiotics-­induced changes in iron metabolism can ameliorate chronic organ damage in SCD mice. Iron-­related
changes in microbiota will be verified by germ-­free SCD mice. These proposed studies, focused on strategies of
microbiota manipulation in SCD, will allow us to identify the key microbial species that contribute to SCD
pathophysiology, and provide potential novel cost-­effective approaches for management of SCD’s life-­long
complications.

Public health relevance
Project Narrative: Sickle cell disease (SCD) patients suffer from repetitive, intermittent and painful blood vessel blockages and can succumb to premature death caused by accumulating defects in all major organs. Our preliminary data suggest one or more specific gut bacterial species can reduce both SCD acute vaso- occlusive crises and chronic organ damage. The proposed studies will advance our understanding of SCD pathophysiology, and may lead to the development of new microbiome- based therapies for SCD patients so they can live longer and with more fulfilling lives.